Integrative Genomics

Abstract Shared Resource 06: Integrative Genomics (IG-SR)
The Integrative Genomics Shared Resource (IG-SR) combines the expertise and instrumentation of two
facilities—COH Integrative Genomics and Bioinformatics Core and TGen Collaborative Sequencing Center —to
provide an integrated array of services for genomics and bioinformatics. The overall goal of the IG-SR is to
provide comprehensive genomic and bioinformatics services to COHCCC Members. The IG-SR accomplishes
this goal using state-of-the-art genome technologies and innovative analytical methods supported by a dedicated
team of instrument operators and bioinformaticians. The SR is co-directed by Drs. Xiwei Wu (COH) and Jonathan
Keats (TGen).
Specific Aims for IG-SR:
Aim 1. Provide cost-effective access to cutting-edge genomic technologies.
Aim 2. Facilitate the design and optimization of complex genomic projects.
Aim 3. Provide bioinformatics support for data generated by COHCCC Members and from public data
sources.
The IG-SR is equipped with major instrumentation for genomic analyses, including an Illumina NovaSeq 6000,
NextSeq 2000, NextSeq 500, iSeq 100, 2 MiSeqs, a PacBio Sequel IIe, multiple 10X Genomics Chromium
instruments, a Mission Bio Tapestri, and an Illumina iScan system. These instruments enable a wide range of
genomic studies. These include: RNA analysis (transcriptome sequencing [ribosomal rRNA depletion], mRNA-
seq, circRNA-seq, small RNA-seq [miRNA], full length isoform-seq); DNA analysis of whole genomes or targeted
sequences (SNP/INDEL, structural variants, copy number); protein and DNA/RNA interaction (ChIP-seq and
RIP-seq); DNA methylation (WGBS-seq, RRBS-seq, EPIC methylation array); genome-wide and custom
genotyping (SNP arrays); and single cell genomics and transcriptomics (scRNA-seq, scDNA-seq, scVDJ-seq,
scCITE-seq). An Eppendorf epMotion and an Agilent Bravo Automated Liquid Handling Platform are used for
automated library preparation. IG-SR also has multiple ABI ViiA 7 Real-time PCR systems, for library
quantification and expression validation, as well as multiple instruments for sample and library QC.
The IG-SR recently launched several new services, including multiOMICS single cell sequencing, spatial
transcriptomics, and improved long read sequencing. The bioinformatics support has been expanded , allowing
more efficient and in-depth data analysis support.
Members Utilization by %Revenue 2017–21: 87.2 Total (29.6 MCBC, 10.4 DCT, 9.8 CI, 20.8 HM, 16.7 CCPS)
Publications by Members: 210, 69 with Impact Factor >10
Grants Supported: 177 Total (6 ACS, 6 CIRM, 9 DoD, 4 LLS, 79 NCI of 177 NIH (1 P01, 96 R01, 8 U01))